Structural Basis of Coreceptor Recognition by HIV-1 Envelope Spike

Project Summary
HIV infection begins with fusion of viral and target cell membranes, driven by the viral envelope glycoprotein
[Env; trimeric (gp160)3 cleaved to (gp120/gp41)3]. Gp120 binding to primary receptor CD4 and coreceptor (e.g.
chemokine receptor CCR5 or CXCR4) trigger large structural rearrangements in gp41 that drive the membrane
fusion process. Encounter of the coreceptor by gp120 is believed to be the crucial trigger for gp41 refolding
events, which promotes membrane fusion. It has been two decades since CCR5 and CXCR4 were first
identified as the coreceptors for HIV-1 entry, but we still do not have a clear picture, in particular, at atomic
resolution, of how the coreceptor recognizes HIV-1 Env, except for some speculative molecular modeling. The
coreceptors are chemokine receptors with seven transmembrane-spanning segments (7TMs) and belong to
the family of G protein-coupled receptors (GPCRs). Crystal structures have been reported for heavily modified
CCR5 and CXCR4, revealing the general architecture of these receptors, as well as their interactions with the
various ligands, but the structures fall short of explaining the molecular details of how these chemokine
receptors function as HIV-1 coreceptors. In this proposal, we plan to gain a better understanding of the HIV-1
coreceptor function of CCR5 and CXCR4 and to provide high-resolution pictures of how they interact with HIV-
1 Env to promote viral entry. We hypothesize that an extensive interface between gp120 and the
coreceptor involving multiple structural elements is required for their high-affinity interaction. We have
already purified a stable complex of HIV-1 gp120, 4 domain CD4 and an unmodified human CCR5, and
demonstrated the feasibility to carry out electron microscopy (EM) studies. Recent advances in cryo-electron
microscopy (cryoEM) have revolutionized the field of structural biology and produced numerous high-resolution
structures. To capitalize on these advances, we will tackle a challenging problem that is important to both the
HIV and GPCR fields. We will pursue following specific aims: 1) we will determine the high-resolution structure
of the complex of CD4-gp120-CCR5 by cryoEM; 2) we will determine the high-resolution structure of the
complex of CD4-gp120-CXCR4; 3) we will elucidate the role of key structural elements of CCR5 or CXCR4 in
coreceptor function by structure-guided mutagenesis.

Public health relevance
Project Narrative Interactions between HIV-1 envelope spike (Env) and its primary receptor CD4 and coreceptor (e.g. chemokine receptor CCR5 or CXCR4) promote fusion of viral and target cell membranes to initiate infection. Molecular details of how the coreceptor recognizes Env remain elusive. This proposal aims to fill this critical knowledge gap by obtaining atomic structures of the Env-coreceptor complexes and analyzing the functional roles of the coreceptor in viral infection.